Signal Processing And Instrumentation Section

The Signal Processing and Instrumentation Section (SPIS) provides electrical, electronic, electro-optical, computer, and software engineering expertise to the NIH Intramural Research program for projects that require the development of biomedical instrumentation and signal processing systems. These SPIS collaborations involve advanced signal transduction and acquisition; real-time signal and image processing; and robotic control systems. Most collaborations result in the creation of new biomedical/clinical systems, instrumentation, and techniques, comprised of custom hardware and application specific software. Example technology developments and projects include: cDNA and protein microarray; tissue microarray; laser capture microdissection (LCM); expression microdissection (xMD); chromosome microdissection; microfluidics, microfabrication, and microanalysis; single molecule, DNA, and chromatin fiber mechanics and manipulation; high-speed scanning spectrometry; atomic force microscopy (AFM); electron paramagnetic resonance (EPR) imaging; magnetic resonance imaging (MRI) and functional MRI (fMRI) methodologies and devices; magnetic resonance elastography (MRE) imaging; ultrasound imaging; positron emission tomography (PET) imaging; fluorescence imaging; speech acquisition and real-time adaptive processing; biomechanics real-time gait analysis; neuro-specific nociceptive assay for mouse pain studies; nonhuman primate maternal-fetal monitoring; and automated video-based mouse activity monitoring. These SPIS capabilities and accomplishments have established the group as the focal point for this type of engineering research and development at the NIH. The research and development activities of the section are collaborative efforts with NIH Institute scientists, and often result in the development of unique, specialized biomedical instruments. Other projects involve signal and video processing algorithm development required for system simulation and signal analysis. Section goals necessitate design expertise in advanced analog and digital circuitry, biophysical signal transduction techniques, radio-frequency and telemetry systems, digital signal processing hardware and software, programmable logic devices, printed circuit board development, electromechanical devices, opto-electronics, video imaging, and computer based instrumentation for signal processing and control.